CARDIOPULMONARY BYPASS OR PIECES OF HUMAN NON VALVED ALLOGRAFTS

Human non-valved allografts in pediatric congenital heart disease surgery: Is an antibody response elicited in the recipient?The hypothesis being tested in this study is that implantation of a human allograft during pediatric cardiac surgery causes an antibody response in the recipient, which accelerates allograft calcification and dysfunction. The specific aim of this protocol is to determine if allograft implantation induces an antibody response in the recipient manifested as an elevated panel-reactive antibody (PRA) in the recipient.